CORE B- Animal Models and Tissue Analysis

Project Summary
The primary goal of this Program Project is to understand the molecular mechanisms by which the physiological
and pathophysiological functions of integrins are regulated in blood and vascular cells. The “Protein Expression
and Purification” Core B will assist each of the three projects realize this common goal by providing the proteins
and cDNAs needed to analyze these molecular mechanisms. The proteins needed by the projects of the program
are integrins, talin, kindlins, IRAK1, paxillin, and fragments of these proteins. The cDNAs needed are for
expression of the integrins, talin, paxillin, kindlins, and IRAK1, mutant forms of and fragments of these proteins.
By providing well-characterized proteins and cDNAs, this core creates reliable reagents that are useful to all
three Projects of the Program. To address the structure-function relationships proposed in each project of the
program requires substantial amounts of the wild-type and mutant forms of the target proteins. Both bacterial
and mammalian expression of proteins is needed. The centralization of protein expression and mutagenesis
avoids unneeded replication of procedures within individual laboratories, provides access to equipment that is
needed for protein expression and purification, and allows these tasks to be performed efficiently and
economically by experienced personnel. There is also a training element to Core B. The Core personnel will train
fellows and technical staff within the individual projects to perform protein purification, bacterial and mammalian
expression, mutagenesis strategies and in protein characterization approaches.